FASEB's Mobile DNA: Evolution, Diversity, and Impact Conference.

Mobile elements continue to play a major role in restructuring their host genomes. Since the discovery of transposons, the main focus has been on their contribution to germ line diseases, which is proven to be relevant to human health. The major departure of the 2021 FASEB conference from this line of thinking is its focus on the TE contribution to somatic genetic variation and its impact on normal aging and age-associated diseases, specifically those involving transformation or degeneration. Integration of this research direction into the FASEB “Mobile DNA: Evolution, Diversity, and Impact” meeting sets it apart from previous FASEB conferences as well as other TE- and aging-related meetings. Three members of the organizing committee, including the organizer of the conference, are NIA-funded investigators. One member of the committee, Dr. Steven Austad, is a prominent member of the aging field. Four US National Academy of Sciences members and two members of the European Academy of Sciences agreed to present at the conference and participate in the career development and meet-the-expert sessions. Our 2021 FASEB conference was scheduled for June 6-9 in Dublin, Ireland. Having an international location for the first time in the history of this conference is beneficial because both fields are strong in Europe. The European location will also make travel easier (i.e. fewer visa restrictions) and less expensive, which will increase attendance. In response to COVID the FASEB has changed the format to a 2- day virtual conference in June 8-9, 2021, followed by the traditional on-site conference in June 5-9, 2022. This format is beneficial to our goals of establishing and fostering collaborations between the two fields of research.

Public health relevance
Time and location. Support is requested for the 9th FASEB conference “Mobile DNA: Evolution, Diversity, and Impact” that, due to the COVID-19 pandemic, morphed into a split format of a two day virtual conference in June 8-9, 2021 and an onsite meeting in June 5-9, 2022 in Dublin, Ireland. The latter may consider offering virtual participation for any scientists who may still be affected by the pandemic, i.e. visa restrictions, health or family leave issues, or any other unforeseen circumstances that may prevent their in-person participation. Theme – TEs and Aging. In the last several years, researchers from the mobile element and aging fields have made key discoveries that are the basis for this conference. The most significant of these are (i) establishing transposable element (TE) expression and mobilization in somatic tissues, (ii) experimentally connecting transposition and resulting genome instability with recurring cancer-causing mutations, senescence, SASP, neurological diseases, and inflammation, (iii) multisystem suppression of TE-associated damage by host DNA repair, epigenetic maintenance, RNA processing, circadian or other systems. These discoveries point to the likely major impact of TEs on age-associated diseases and normal aging. A unique feature of the 2021/2022 conference that sets it apart from previous FASEB meetings and other TE or aging conferences is a deliberate push for understanding the connection between TEs, phenotype, and aging in different model systems. Our proposed program comprises all potential points of connection between TEs and aging, making it a useful overview of both fields. We also put together a mix of TE and aging investigators that will promote thoughtful discussions and inter-disciplinary collaborations. The conference will bring experts who developed and validated techniques for the proper analysis of repetitive sequences with the goal to identify novel associations between transposons and epigenetic marks, gene networks, host immune, DNA repair and circadian systems as a function of age. Goals. The objective of the 2021/22 FASEB conference is to build on this trend by bringing together investigators with common interests in mobile DNA and its impact on somatic and germline genomic variation, the aging process, and age-associated pathologies. The main goal of the conference is to synergize the TE and aging fields. Thus, the meeting will focus on highlighting transposon impact on age-associated diseases as well as models and technologies that are available for rigorous TE analysis with the intent to improve our ability to screen, diagnose, and/or treat these diseases. Innovations. The conference will facilitate sharing of unpublished findings and discussion of experimental challenges and outstanding questions in these two rapidly evolving fields among students, postdoctoral trainees, junior and senior principal investigators. This is particularly valuable because TEs do not conform to Mendelian genetic principles alone, and therefore require unique approaches for their analysis. Additional innovations of the meeting are: (i) “confidence conference” to establish the field's consensus on the use of technical tools suitable to study TEs, (ii) a competition session to determine relative efficiency and accuracy of existing bioinformatics approaches for TE identification, (iii) an outreach program to attract participation of minority scientists, (iv) commitment to participate from multiple NIH institutes, (v) a shift in the leadership of the conference organizing committee to include Dr. Steven Austad, UAB, a world-renowned expert in evolutionary and aging biology, (vi) for the first time the majority (3/5) of the organizing committee are female scientists. These steps underscore the scientific strength and depth of the field's expertise as well as the support of transposable element community for inclusivity, innovation, and diversity of opinions and experiences.